Postpartum health care receipt among immigrant women in the United States

PROJECT SUMMARY
The postpartum period, defined as the three months after childbirth, is a critical and often neglected period for
maternal health. Routine postpartum health care, including testing for common postpartum health conditions
and counseling on breastfeeding and contraception, is recommended by the American College of Obstetricians
and Gynecologists for all postpartum women. Medicaid coverage during pregnancy, which pays for the health
care costs associated with forty three percent of births in the United States, covers women for at least 60 days
after childbirth. While the majority of low-income women qualify for Medicaid during pregnancy, most states
limit eligibility to citizens or lawfully residing immigrants with greater than five years of legal residence. States
offer a patchwork of alternative public coverage options, such as Emergency Medicaid, to cover the cost of
labor and delivery for women who are not eligible for traditional Medicaid coverage because of their
immigration status. Unlike traditional Medicaid, these coverage alternatives often do not cover health care
during the postpartum period. Little is currently known about what specific services are covered under
alterative public coverage options for childbirth in each state, and how this may affect postpartum outcomes
among immigrant women. This research has four aims:
In Aim 1, we will create the first database linking data from the Pregnancy Risk Assessment Monitoring System
(PRAMS) with information on maternal place of birth from birth certificate records.
In Aim 2, we will document state variation in public coverage policies for immigrant women during pregnancy in
PRAMS states (including undocumented women and legally residing non-citizens)
Aim 3 will use the data compiled in Aim 1 to compare postpartum health care use (including contraceptive
use), health outcomes and health behaviors between women born within and outside the U.S.
Aim 4 will use the dataset created in Aim 1, and the policy information compiled in Aim 2, to examine the
association between state policies for public coverage of immigrant women during and after pregnancy and
disparities in postpartum care utilization, health outcomes and health behaviors between postpartum women
born within and outside of the US
This project will be the first study to examine the association between maternal place of birth and postpartum
care receipt, and the first to examine the relationship between state public coverage for immigrant women
during pregnancy and postpartum care in this population. The results of this study will provide information to
public health practitioners and policy makers about whether there are disparities in health care use after
pregnancy between immigrant women and women born in the United States. Further, this study will contribute
to our understanding of the relationship between state insurance coverage policies for pregnant and
postpartum immigrant women and postpartum health care use.

Public health relevance
PROJECT NARRATIVE In the United States, nearly one quarter of women giving birth were born outside of the United States, and an estimated one out of every 13 births in the country is to an undocumented immigrant mother. While most low- income women are eligible for Medicaid during and after pregnancy, in many states low-income undocumented and recent immigrants are not eligible for pregnancy Medicaid and are covered instead by less generous programs which often do not cover postpartum care. This project will examine whether postpartum outcomes vary between foreign-born and US-born low-income women, and will examine the relationship between state public coverage policies for pregnant and postpartum immigrant women and disparities in postpartum care between foreign and US-born women.